Genetic modifiers of Alzheimer Risk Administrative Supplement

Genetic Modifiers of Alzheimer Risk Administrative Supplement We have identified a blood biomarker signal that differentiates genetically mutant Alzheimer disease (AD)-model mice from their age- and sex-matched non-mutant littermates: markers of the cellular response to DNA damage. This supplement to the KOMP project will define the detection limits of the assay signal in time, pre-disease, and breadth of models detectable, and will examine viable knock-out mice generated in the KOMP project for signal in the blood assay as a simple screen for knock-outs with AD and pre-AD properties. This work has the potential to identify new AD risk alleles, and to produce a simple, early initial blood-based biomarker and assay for AD risk. Simple blood screens for pre-AD phenotypes could allow identification and potentially prevention of symptoms in at-risk individuals not otherwise identified.

Public health relevance
Project Narrative The purpose of this supplement to the Baylor College of Medicine Knock-Out Mouse Production and Phenotyping project (KOMP2) is to develop a promising blood-based assay for early detection of Alzheimer disease (AD) in the pre-clinical mouse model, and to screen knock-out mice generated by the KOMP2 for knock outs that predispose to AD. This work may advance early detection and prevention of AD.